Comparison of High vs. Standard Dose Influenza Vaccines in Adult Solid Organ Transplant Recipients

PROJECT SUMMARY
Influenza virus is a significant pathogen in adult solid organ transplant (SOT) recipients. However, these
individuals respond poorly to standard-dose (SD) inactivated influenza vaccine (IIV). Recent studies have
investigated two strategies to overcome poor immune responses in SOT recipients: (1) administration of high-
dose (HD)-IIV compared to SD-IIV and (2) two doses of SD-IIV compared to one dose of SD-IIV in the same
influenza season. The first study compared HD-IIV vs.SD-IIV in adult SOT recipients and noted that HD-IIV
was safe and reported higher immunogenicity; however, the median post-transplant period was 38 months. In
another phase II trial of adult SOT recipients, two doses of SD-IIV a month apart compared to one-dose of SD-
IIV revealed increased immunogenicity, with a median post-transplant period of 18 months. Therefore, these
studies lack evaluation in the early post-transplant period in this vulnerable population. Additionally, the
administration of two-doses of HD-IIV in the same influenza season has not been evaluated in SOT recipients.
Thus, the optimal immunization strategy for SOT recipients less than 12 months post-transplant is unknown. In
addition, the immunologic predictors and correlates of influenza vaccine immunogenicity in SOT recipients
have not been well-defined. The central hypothesis of our proposal is that adult SOT recipients that are
1-11 months out from transplant and are receiving two doses of HD-IIV will have higher
hemagglutination inhibition geometric mean titers (GMT) to influenza A antigens compared to adult
SOT recipients receiving two doses of SD-IIV over one influenza season. To test this hypothesis and
address the critical knowledge gaps outlined above, we propose to conduct a phase II, multi-center,
randomized-controlled immunogenicity and safety trial comparing either one dose of HD-IIV, two doses of SD-
IIV, or two doses of HD-IIV in adult kidney, heart, and/or liver SOT recipients 1-11 months post-transplant. The
results of this study will address significant knowledge gaps regarding influenza vaccine strategies and
immune responses in adult SOT recipients and will guide vaccine recommendations in the early post-
transplant period.

Public health relevance
Narrative Influenza virus is a significant pathogen in solid organ transplant (SOT) patients, but these individuals respond poorly to standard-dose (SD) inactivated influenza vaccine (IIV). Studies suggest that two doses of SD-IIV or one dose of high-dose (HD-IIV) is superior to one dose of SD-IIV; however, this has not been tested in the early post-transplantation period when SOT recipients are at highest risk of severe influenza disease and complications. This study aims to find the optimal influenza vaccine strategy by comparing one dose of HD-IIV, two doses of SD-IIV, or two doses of HD-IIV over one influenza season in adult, kidney, heart, and/or liver SOT recipients in the early transplant period.